Acquisition of an 800 MHz NMR Spectrometer Console and Probes

Funding is requested to obtain a Bruker Biospin NMR AVANCE NEO 800 MHz Console and
associated components, including BMPC-2 magnet control system, CryoPlatform/5, MASIII
pneumatic control unit, TCI-H&F triple-resonance CryoProbe, MAS tri-gamma 1.9 mm solid-state
probe, and MAS 3.2 mm solid-state CryoProbe, to be installed on an existing Bruker Biospin 800 MHz
NMR magnet system. The present NMR AVANCE I console and TCI CryoProbe/1 were installed
2003 and 2004 and were declared by Bruker Biospin to have reached “End of Service” (EOS) in 2018
and 2019, respectively. The requested instrumentation provides enhanced sensitivity and capabilities
for modern NMR experiments, including temperature-locking, non-uniform sampling, complex
waveform generation, magic-angle spinning (MAS) solid-state NMR spectroscopy, and advanced
cryogenic probe design for both solution and solid-state MAS applications. The requested
instrumentation is essential to the over-riding purpose of the New York Structural Biology Center
(NYSBC), a consortium of nine research institutions in New York State, to support the specific aims of
the NIH-funded research of the major and minor users of the spectrometer. Research conducted on
the 800 MHz NMR Spectrometer ranges from fundamental studies of structure/function of
biomolecules, to elucidation of mechanisms of pathogenesis, to discovery of novel lead compounds
to pharmaceutical applications. The requested instrumentation will dramatically enhance the capacity
of the 800 MHz NMR spectrometer to conduct this research.

Public health relevance
Narrative The New York Structural Biology Center (NYSBC), a consortium of nine research institutions in New York State, houses and supports ultra-high field (>600 MHz) NMR spectrometers used by scientists at member institutions. The requested NMR console and probes will be installed on an existing 800 MHz NMR magnet system at NYSBC. The new instrumentation replaces obsolete instrumentation, provides new capabilities, particularly for solid-state NMR spectroscopy, and will enable research ranging from understanding fundamental biological processes in normal and pathological states to discovery of potential new drugs for treatment of cancer and other diseases.